Sirtuin 3 Inactivation and SOD2 Acetylation in Vascular Dysfunction and Hypertension

Project Summary
Vascular dysfunction plays a key role in hypertension and cardiovascular disease associated with inactivation of
mitochondrial deacetylase Sirt3, but mitochondria-targeted treatments are not available. Sirt3 inactivation induces
inhibition of mitochondrial superoxide dismutase (SOD2) and impairs fatty acid metabolism leading to mitochondrial
oxidative stress and formation of harmful lipid peroxidation products, isolevuglandins (isoLG). We suggest that a feed-
forward cycle between Sirt3 inactivation and mitochondrial isoLG promotes vascular dysfunction and hypertension.
We developed new mitochondria-targeted isoLG scavenger, mito2HOBA, which protects Sirt3 activity and attenuates
hypertension. In this proposal, we will advance this research by defining the novel role of mitochondrial isoLG in
Sirt3 inactivation and vascular dysfunction, and we will establish the therapeutic potential of targeting mitochondrial
isoLG. Our overall objective is to define the specific mechanism of isoLG-mediated Sirt3 inactivation and directly test
the therapeutic potential of targeting mitochondrial isoLG using new transgenic mice, new mitochondria-targeted
drugs, and vascular tissue from patients with essential hypertension. We will pursue the following aims:
AIM 1.Test the hypothesis that inactivation of endothelial Sirt3 induces endothelial dysfunction which is prevented
by targeting mitochondrial isoLG. In this aim we will examine the pathophysiological role of endothelial
Sirt3 impairment and mitochondrial isoLG in endothelium specific Sirt3 depleted (EcSirt3KO) and wild-type
male and female mice. We will define the role of Sirt3 inactivation and mitochondrial isoLG in endothelial
inflammation, cell senescence, endothelial barrier disruption, and impaired relaxation.
AIM 2.Test the hypothesis that inactivation of smooth muscle Sirt3 induces vascular dysfunction, and blocking
mitochondrial isoLG improves vascular function. We will study the role of smooth muscle Sirt3 impairment
in smooth muscle Sirt3 depleted (SmcSirt3KO) mice. The specific roles of SOD2-K68 acetylation and metabolic
dysfunction will be tested in available SOD2-deacetylation mimetic SOD2K68R and Sirt3-/--SODK68R mice. The
role of mitochondrial isoLG in smooth muscle hypertrophy, inflammation and aortic remodeling will be defined.
AIM 3. Determine the therapeutic potential of targeting Sirt3 inactivation and mitochondrial isoLG in mouse models
and human vascular tissue from patients with essential hypertension. We will test (A) if treatment with novel
mitochondria-targeted isoLG scavengers, such as mito2HOBA, after onset of hypertension increases Sirt3
activity and improves vascular function in mouse models, and (B) if targeting mitochondrial isoLG in vascular
tissues from hypertensive human subjects ex vivo reduces inflammation, improves Sirt3 activity, and relaxation.
We are in an ideal position to perform these interdisciplinary studies. We developed new Sirt3 transgenic mouse
models and mitochondria-targeted treatments. We have access to human vascular tissue and unique expertise
in oxidative stress, human vascular studies and hypertension. Our data support this novel pathway in vascular
dysfunction, and this work has the potential to make a major impact on the development of new clinical treatments.

Public health relevance
Project Narrative Vascular dysfunction contributes to pathogenesis of stroke, myocardial infarction, hypertension and heart failure, which cause one-third of deaths worldwide; however, there have been no mechanistically novel treatments for vascular dysfunction in the past 30 years. Vascular dysfunction and human hypertension are associated with mitochondrial dysfunction and oxidative stress which produce highly reactive cytotoxic isolevuglandins and inactivate a key of mitochondrial regulator, Sirtuin 3. In the proposed studies, we will define the novel role of mitochondrial isolevuglandins in Sirtuin 3 inactivation and vascular dysfunction, and we will establish the therapeutic potential of our new mitochondria-targeted blockers of isolevuglandins in vascular tissue isolated from hypertensive patients which can make a major impact on the development of new treatments.